The metabolomic consequences of small size and long life

Project Summary
This research proposal has been developed to equip the candidate, Dr. Jessica Hoffman, with the experience,
skills, and tools needed to successfully transition into a faculty position at a large public research university. The
proposed research will discover novel metabolic mechanisms that lead to small size and long life across natural
genetic variation and lifespan extending interventions with a specific focus on the degradation of tryptophan to
kynurenine. Dr. Hoffman will receive extensive training in mouse husbandry techniques, molecular biology, and
metabolomics data acquisition and analysis under the guidance of her mentorship team, Drs. Steven Austad,
Stephen Barnes, and Liou Sun, all at the University of Alabama at Birmingham and active members of UAB's
Nathan Shock Center for Excellence in the Biology of Aging. Preliminary studies completed under the direction
of Dr. Steven Austad indicate size plays a large role in explaining the variation in metabolomic profiles within a
species (companion dogs) that show a negative correlation between body size and longevity. And work with Dr.
Sun suggests that metabolomic profiles are different between small, long-lived growth hormone (GH) disrupted
mice and wild type mice. One pathway found to be similar between the two species is the breakdown of
tryptophan to kynurenine. In both small dogs and small GH disrupted mice kynurenine levels are higher and
tryptophan levels are lower than their larger counterparts. This suggests that the degradation of tryptophan to
kynurenine may be influencing the longevity extension seen in small individuals of a species. The overall goal of
this project is to expand our knowledge of small size and long life and to further tease apart the molecular
mechanisms that underlie the size longevity tradeoff seen across species. The overarching hypothesis is that
tryptophan metabolic dysregulation is partially modulated by GH and energy intake and provides an IGF-
I independent mechanisms of long-life and small body size across species. This hypothesis will be
addressed by three specific aims, each of which will help develop Dr. Hoffman as an independent investigator.
1) Determine the dynamics of tryptophan metabolism to the longevity effect of reduced GH activity. 2) Determine
how metabolomic profiles, specifically tryptophan degradation metabolism varies across different interventions
that show smaller size and longer life across species. 3) Determine lifespan consequences of genetic
manipulation of tryptophan metabolism genes in fruit flies. Overall, this proposal will increase our knowledge on
the molecular underpinnings that lead to variation in body size and lifespan and will provide new hypotheses
about potential interventions to improve lifespan and healthspan.

Public health relevance
Project Narrative One repeated feature of a number of longevity-extending interventions in animal models is that they result in reduced body size; in addition, a similar pattern in seen in natural genetic variation of wild type animals where small mice and dogs are longer lived than their larger counterparts. One pathway that has been found to be associated with age and body size is tryptophan metabolism to kynurenine; however, the direct of effects of tryptophan metabolism manipulation on aging and longevity are unknown. Here, I attempt to discover the metabolic changes that are associated with size and lifespan with specific focus on tryptophan degradation to kynurenine with the goal of developing a potential new target for lifespan and healthspan interventions.